CVM Vet-LIRN Veterinary Diagnostic Laboratory Program

Project Summary/Abstract: Through this cooperative agreement, the Indiana ADDL at Purdue University with its diagnostic personnel and testing capabilities, will work with the FDA CVM Vet-LIRN to meet its goal to complement, develop, improve and use university, state, and federal veterinary diagnostic laboratories testing programs. This will be done by addressing three key project areas: 1) through participation in FDA/Vet-LIRN sample analysis, 2) by providing analytical data to support potential regulatory use, and 3) through participation in additional projects such as small-scale method development and/or method validation and matrix extension work as determined by the Vet-LIRN Program Office (VPO). In the event that laboratory surge capacity is needed by Vet- LIRN and the FDA for analyses related to microbiological or chemical contamination, either through intentional or unintentional means, participation of the Indiana ADDL will help enable the analyses of animal diagnostic samples and animal food/drug products submitted to the ADDL through Vet-LIRN. Analyses of samples by the ADDL and other veterinary diagnostic laboratories will facilitate early detection of animal food/drug adulteration or contamination contributing to overall food safety for animals and humans. In addition, the ADDL will work with the FDA CVM and other network laboratories to facilitate methods standardization, training and proficiency testing.

Public health relevance
Project Narrative This project is relevant to Public Health because the contribution of the Indiana Animal Disease Diagnostic Laboratory at Purdue University to the Vet-LRN program will add an additional component to FDA's Office of Regulatory Affair's usual investigations and testing programs, i.e., the examination of veterinary diagnostic samples. Examination of such samples will greatly facilitate early detection of animal food/drug adulteration or contamination. These efforts can contribute to overall food safety as animal food events could signal potential issues in the human food system.